Molecular mechanisms of Helicobacter pylori trans-kingdom DNA conjugation

PROJECT SUMMARY
Of the recognized infection-associated malignancies, the most significant carcinogenic microbe is the gastric
bacterium Helicobacter pylori, which chronically colonizes the stomach of over half of the global population and
contributes to the development of more than one million new cases of cancer per year. Despite many decades
of research, we do not fully understand how H. pylori balances interactions with the human host to stimulate the
development of gastric disease. The cancer-associated H. pylori cag type IV secretion system (cag T4SS) has
emerged as a paradigm for understanding how a single molecular device transports diverse immunostimulatory
cargo into target eukaryotic cells. Whereas some T4SSs have the capacity to secrete multiple protein effectors,
the ability to translocate a pro-inflammatory bacterial oncoprotein and a repertoire of DNA and polysaccharide
substrates distinguishes the cag T4SS from other nanomachines. In exciting new studies, we discovered that
cag T4SS-dependent trans-kingdom DNA conjugation stimulates cytosolic nucleic acid reconnaissance systems
to provoke the production of multifarious interferons and inflammatory cytokines that orchestrate diverse immune
responses. Our long-term objective is to mechanistically characterize how the dynamic cag T4SS transports
carcinogenic molecular cargo into gastric cells. Towards our objective, we aim to define the kinetics and
biogeography of cag T4SS-dependent DNA translocation in vivo and delineate the mechanism by which
chromosomal DNA cargo is excised and coupled to the cag T4SS apparatus. Our studies will employ rodent
infection models, high-resolution microscopy, biochemical approaches, and immunological assays to address
longstanding knowledge gaps in gastric cancer biology and uncover microbial mechanisms that are involved in
the development of pre-malignant lesions. Collectively, these investigations will advance our understanding of
important host-pathogen conflicts that engage nucleic acid surveillance pathways to regulate host immunity and
trigger microbial carcinogenesis. Furthermore, our studies will provide the foundational framework for developing
new treatment and intervention strategies to reduce the incidence and severity of malignancies that arise as a
consequence of infection-induced chronic inflammation.

Public health relevance
PROJECT NARRATIVE Helicobacter pylori chronically colonizes the stomach of more than half of the global population and is the strongest known risk factor for the development of gastric cancer. The proposed studies will explore the mechanisms by which H. pylori delivers microbial DNA into gastric cells trigger innate immune signaling. These investigations will advance our understanding of how an important bacterial carcinogen regulates host immunity to promote chronic inflammation and stimulate the development of stomach malignancies.